The Florida Summer Training in Research and Oncology for the Next Generation of Researchers (STRONGER) Program

ABSTRACT
One of every five deaths in the United States is due to cancer. In both men and women, it is the second leading
cause of death, exceeded only by heart disease. However, it is the leading cause of death among women aged
40 to 79 years and men aged 60 to 79 years. Furthermore, cancer is primarily a disease of the aged and the
nation’s population is aging. By 2050, about one in five Americans will be age 65 or older, up from about one in
eight in 2000, and the number of Americans aged 65 and older will more than double over the 40-year period,
reaching more than 80 million in 2050. It is therefore imperative that we ensure a continuous workforce of highly
trained cancer researchers who will discover, through research, new therapies and preventative strategies that
improve treatment outcomes and reduce cancer-related mortality and morbidity. We believe that this goal will be
achieved through educating and training the next generation of cancer research scientists.
Experiential research internships have been shown to be effective in encouraging students to matriculate to
graduate schools and to consider research careers. R1 institutions, classified as doctoral universities with very
high research activity, offer abundant opportunities for undergraduate research. However, students completing
their Baccalaureate degrees at non-R1 institutions may be disadvantaged due to lack of access to equivalent
research experiences. Furthermore, since R1 institutions comprise only a small fraction of degree-granting
institutions, it is becoming increasingly clear that in order to meet the expanding need for a highly trained cancer
research workforce, it is essential to strengthen the pipeline of potential future researchers. We believe the
strategy to achieve this goal, while simultaneously providing career and skills development to enhance future
career aspirations, is to offer undergraduates from non-R1 universities the opportunity for hands-on, immersive
research experiences that will enhance their graduate portfolios, strengthen their academic competitiveness and
aid their preparation for competitive PhD program acceptance.
We are requesting support for 8 baccalaureate trainees (rising juniors, seniors, and postbaccalaureates) annually
from non-R1 institutions, including Historical Black Colleges and Universities, Hispanic-Serving Institutions, and
rurally located colleges to participate in our Summer Training in Research and Oncology for the Next Generation
of Researchers (STRONGER) Program. The program will directly link the interns with graduate students in the
laboratories of a cadre of outstanding cancer research faculty, with broad research expertise, to provide the
interns with a near-peer mentoring experience in a team-based cancer research setting. Coupled with the
University of Florida’s unique scientific resources and infrastructure, the STRONGER program will expose
students to a broad range of cancer research disciplines and provide a path to future careers in cancer research.

Public health relevance
NARRATIVE The goal of the STRONGER Program is to increase the opportunities for undergraduate and postbaccalaureate students from non-R1 institutions, which do not have the broad academic spectrum of graduate research opportunities, research funding, and access to accomplished researchers offered at R1 institutions, in order to enhance their academic competitiveness for graduate school positions by exposing them to immersive cancer research experiences and promoting a path to future careers in oncology.